Immune Epitope Database: Infectious diseases

The Immune Epitope Database and Analysis Program contains extensively curated antibody and T cell epitope information from the published literature, as well as tools to predict antibody and T cell epitopes or visualization/mapping of epitopes onto known protein structures. Over 7,000 references have been curated into the IEDB, which includes epitopes for NIAID's category A-C prioroity pathogens such as lassa fever virus, hantavirus, ricin toxin, ebola virus, and marburg virus. In addition, the IEDB hosts a series of epitope analysis tools such as antibody and T cell epitope prediction algorithms, epitope homology discovery, HLA frequency analysis, and 3D epitope viewer/protein mapping tools.